Purposeful Outreach for Diversity and Inclusion of Underrepresented in Medicine (PODIUM) Physician-Scientists

We propose the “Purposeful Outreach for Diversity and Inclusion of Underrepresented in Medicine (PODIUM)
Physician-Scientists” T32 Program to train and increase the number of investigators from under-represented in
medicine (URM) backgrounds, committed to research relevant to cardiovascular, pulmonary, and hematologic
diseases, and sleep (HLBS) disorders and to also address disparities in health in pediatric and adult
populations. We will apply the strengths of the Albert Einstein College of Medicine (Einstein) and the
Montefiore Health System (Montefiore), with our outstanding record of recruiting a diverse group of trainees
and developing scientists and clinician-investigators, to develop a new generation of diverse scientists highly
trained in HLBS research. This training will occur in the Bronx, the most diverse county in the United States,
where over 95% of the population is of Hispanic or African American heritage. The population in the Bronx also
has high burden of HLBS disorders. Our program includes 28 established faculty mentors conducting funded
HLBS research representing 9 different departments. We request resources to support 3 postdoctoral trainees
who will spend 2 years in training. Our specific aims are (Aim 1) to increase trainee knowledge and skills in
research through hands-on, mentored research from established, senior scientists; (Aim 2) to increase the
number of postdoctoral trainees who pursue academic careers in research; and (Aim 3) to increase the
number of postdoctoral trainees who successfully compete for extramural funding. The training plan will include
individualized curriculum based on the trainee prior experience, competencies and skills with structured
classwork, seminars and workshops that supplement hands-on research with mentors. Emphasis will be
placed on experiential mentored research experiences as well as professional development activities to
prepare the trainees for a research career in academic medicine. The knowledge and skills learned from this
training program and the other educational and professional development activities promoted by PODIUM will
allow this new cadre of URM investigators to advance the HLBS research. We will conduct a careful and
rigorous evaluation of the program to maintain and enhance its quality. To help strengthen the pathway of
diverse scientists, we propose innovative collaborations where PODIUM trainees will serve as career role
models to predoctoral students in established academic programs, such as Bronx Community Health Leaders
(BxCHL), the Einstein Office of Diversity Enhancement (ODE) programs and Leadership, Engagement, and
Diversity in Education and Residency (LEADER) to increase interest of URM students in academic research
careers. Our ultimate goal is to provide the next generation of URM investigators with the state-of-the art
experiences and skills required to initiate and sustain successful independent careers in HLBS research. This
training program brings our institution's considerable depth, rigorous scientific approach, and tradition of
innovation to bear on important and highly prevalent burden of HLBS disorders in our community.

Public health relevance
The “Purposeful Outreach for Diversity and Inclusion of Underrepresented in Medicine (PODIUM) Physician- Scientists” T32 training program will provide advanced research training in heart, lung, blood and sleep (HLBS) disorders to underrepresented in medicine (URM) postdoctoral trainees from established, senior investigators at Einstein-Montefiore. The PODIUM leadership team will implement an individualized curriculum for each trainee with structured classwork, seminars and workshops to supplement the hands-on research with mentors and transition to academic careers. The ultimate goal of the PODIUM T32 program is to provide the next generation of URM investigators with the state-of-the art experiences and skills required to initiate and sustain successful independent careers in HLBS research.